Modulation of gut and brain serotonin signaling by tryptophan producing bacteria

Project Summary
Functional disorders of the gastrointestinal (GI) tract represent a significant burden to patients and to society.
These disorders are difficult to treat, and recurrence of symptoms is common. As a result, there are ongoing
efforts to develop more effective treatment options. The gut microbiome is recognized as a dynamic entity that
can influence a wide variety of physiological processes, ranging from the integrity of the intestinal epithelial
barrier to brain neurochemistry and behavior. Studies included in this grant application are designed to exploit
specific biochemical properties of certain bacterial strains to test the hypothesis that treatment of mice with
bacteria that generate tryptophan (TRP) can improve GI motility and affect anxiety and depression.
In the epithelium of the intestine, and in serotonin (5-HT) neurons, TRP is converted to 5-HT. When 5-HT is
released from these cells it triggers reflexes that increase motility and epithelial secretion in the gut, and
influences emotional well-being in the brain. We have recently demonstrated that Bacillus (B.) subtilis, a TRP-
producing bacteria, can enhance colonic motility in normal and constipated mice through the activation of the 5-
HT4 receptor. This grant proposal aims to elucidate the mechanisms by which TRP-synthesizing bacteria
enhance colonic motility, and to determine whether and how increased circulatory TRP synthesized by gut
bacteria can alter 5-HT signaling in the brain and affect anxiety and depression.
Experiments proposed in Aim 1 will elucidate the mechanisms by which TRP-producing bacteria enhance
motility. We will determine whether increased levels of enteric TRP by various TRP-producing bacteria increase
the 5-HT release and mucus secretion, and whether epithelial 5-HT4 receptors are mediating the prokinetic
effects of TRP synthesizing bacteria. We will test whether administering a TRP decarboxylase-producing
bacteria in combination with a TRP-producing strain will further enhance motility by converting TRP to tryptamine,
which has been shown to activate epithelial 5-HT4 receptors. Finally, we will identify changes in colonic motility
patterns and in myenteric neuroglial activity resulting from this treatment and how these changes enhance
propulsive motility.
Experiments proposed in Aim 2 will determine whether TRP-producing bacteria can affect 5-HT signaling in
brain regions involved in anxiety and depression. Preliminary data have shown that B subtilis treatment increases
serum TRP levels. We will test whether this increase in circulatory TRP by enteric bacteria modify the levels of
TRP and TRP metabolites in the raphe nuclei, hippocampus, amygdala, and prefrontal cortex. In addition, we
will assess whether this treatment results in increased neuronal activity in these regions and affects anxiety- and
depression-like behavior.
The results of these studies could provide a predictive translational bacterial treatment strategy, based on
biochemical features of the bacteria, for the treatment of constipation and associated psychological disorders.

Public health relevance
Project Narrative Microorganisms that are present in the gastrointestinal (GI) tract can synthesize chemicals that have beneficial effects on constipation and other GI diseases. We have demonstrated that tryptophan produced by enteric bacteria can increase intestinal motility, possibly by enhancing serotonin signaling, and now aim to (1) determine the mechanisms by which microbial tryptophan improves GI motility, and (2) test whether bacterial tryptophan can have an impact on levels of anxiety and depression. This project is designed to develop a translational strategy to use individual microbes to treat constipation and other GI motility diseases and improve associated psychological disorders.